Behavioral Economic Approaches for Population-based Colorectal Cancer Screening

PROJECT SUMMARY/ ABSTRACT
This goal of this proposal is to develop and evaluate a multi-level intervention focused on the health
system, clinicians, and patients that could increase colorectal cancer (CRC) screening rates by incorporating
behavioral economic principles. Through partnership with the University of Pennsylvania Health System
(UPHS), we will develop a centralized program of inreach and outreach that includes nudges to clinicians
facilitated by the electronic health record (EHR) and direct outreach to patients’ homes. Through these
interventions, we will evaluate the effectiveness of offering sequential choice of colonoscopy then FIT
compared to colonoscopy only. Through this intervention, we will include behavioral insights such default
options and effort reduction.
We will conduct a pragmatic clinical trial with factorial design across 30 primary care practices among
20,000 patients ages 50-72 who are not up-to-date on screening. Practices will be cluster randomized to
colonoscopy only or sequential choice (colonoscopy then FIT) alerts in the EHR (Aim 1). At the same time,
patients in all of these practices will be randomized to usual care, direct colonoscopy outreach, and sequential
choice outreach of colonoscopy then FIT (Aim 2). Outreach will be provided annually for the 3 year period of
the trial. The primary outcome is adherence to CRC screening. Our hypotheses are that sequential choice will
increase adherence to screening, and patient outreach will be superior to EHR nudges alone.
We will partner closely with the primary care network at UPHS and leverage the EHR to facilitate the
clinic alerts and patient outreach. Our team includes a team of experienced investigators with expertise in
colorectal cancer screening, behavioral economics, health behavior, clinical trials, and health care delivery
science. By embedding the project with clinical operations in a pragmatic trial, this approach could be
applicable to other cancer screening and preventive health activities.

Public health relevance
PROJECT NARRATIVE Colorectal cancer is the 2nd leading cause of cancer death, and despite effective methods for prevention and early detection, screening rates remain low. Recent insights from behavioral economics have shown that reducing effort and providing timely nudges can encourage clinicians and patients to engage with preventive health activities. We will conduct a pragmatic trial evaluating if offering a sequential choice of screening options during clinic visits and through direct patient outreach can increase colorectal cancer screening completion.